Predicting HIV-related Behaviors of Social Networks in a MPS Environment

Mobile personal sensing (MPS) is the assessment of real-time data in situ through a mobile phone. MPS is poised to revolutionize the ability to both assess and self-monitor HIV-transmission risk behaviors. The proposed five-year career award will provide W. Scott Comulada, Dr.P.H., a statistician working in the field of HIV prevention, with protected time and the methodological expertise in MPS to inform the design of MPS- based HIV interventions. During the proposed career award, he will develop innovative methods to integrate information from three data types related to HIV transmission risk over time: social network, diary, and Global Positioning Satellite (GPS) location trace data. Three years ago, Dr. Comulada received a doctoral degree in Biostatisics from the University of California, Los Angeles. He is currently the Associate Director of the Methods Core for the Center for HIV, Identification, Prevention, and Treatment Services (CHIPTS). Dr. Comulada's academic training and recent career path have focused on the development of statistical methodology that will further HIV research. MPS is moving HIV research away from traditional research methods that Dr. Comulada has expertise in. It is critical at this stage in his career that Dr. Comulada be afforded the time and training opportunities needed to become an independent investigator who is at the forefront of methodological development in HIV research. His training will focus on quantitative methods specific to social network and MPS data, the ethical conduct of research, and will build general skills for an academic career. The training plan includes structured coursework and mentoring by a group of experts in social networks, MPS, and HIV intervention design. The aims of the research are to: 1) Expand on established social network statistical models to handle assessment of real-time data in a MPS environment; 2) Develop models to predict behavioral outcomes using previous measurements of the outcome and previous / concurrently measured diary data and GPS location traces; and 3) Expand model from 2) to incorporate social network characteristics as a predictor of behavioral outcomes. A key component of the research will involve designing self-monitoring algorithms that will be based on his proposed statistical models and programmed into a mobile phone. For example, a mobile phone user could be alerted when they are in close proximity to a physical location that may lead to unwanted behavior, such as a bar. The mobile phone self-monitoring application will be pilot tested on persons living with HIV in Los Angeles County, California. Methodology developed from this study will be used by the applicant to inform the design of a MPS-based HIV intervention trial that will be developed in a subsequent R01 application.

Public health relevance
Project Narrative Mobile personal sensing (MPS), i.e. real-time data assessment on a mobile phone, will revolutionize intervention delivery in the behavioral and biomedical sciences. With increasing wide-spread use of more advanced mobile phones, intervention delivery will be more cost effective and offer more treatment options than current delivery methods. Prior to implementation of MPS, new quantitative methods must be developed, such as methods that will be developed during the proposed K01. __SpecificAimsTextDelimiter__ The next generation of HIV intervention research must consider context in a fundamental way (Coates et al., 2008; Gupta et al., 2008): Mobile Personal Sensing (MPS), the next step in Cellular Ecological Momentary Assessment (CEMA; Stone et al., 2007; Shiffman et al., 2008), offers the unique opportunity to better understand, monitor, and shift contexts empirically. Two key contextual factors are the social networks and physical environments of the study participants. Social networks have been shown to influence behavior, e.g. tobacco use (Christakis & Fowler, 2008), and social network-based interventions have been shown to be effective in HIV research (Latkin et al., 2009). Physical environments (Latkin et al., 2005; Parker et al., 2000; Rhodes & Simic, 2005) have also been linked to HIV transmission behaviors, though tools have been lacking to measure and incorporate physical environments into mainstream HIV interventions. MPS is an emerging technology that has the potential to simultaneously measure and incorporate multiple data types (social network characteristics, diary reports, and location) into interventions. Numerous benefits over traditional assessment methods, such as face-to-face interviews, are found. Simultaneous assessment of multiple data types makes for easier validation across measures. For example, self-reported social contacts can be validated with actual social interactions conducted through the mobile phone. Mobile phones are a natural social networking tool that can provide a smoother implementation into study designs than previous social network assessment methods, e.g. interviewer driven queries. Mobile phones act as both an assessment and self-monitoring intervention tool. For example, MPS can assess drug using network ties and alert study participants when they are in close proximity to a drug-using network member. Prior to implementing MPS-based HIV interventions, statistical methods need to be developed to provide a reasonable level of precision in detecting behavioral patterns over time. Reasonable precision in modeling behavior patterns will lead to the accurate prediction of future behaviors. Once behavior modeling and prediction have been refined, HIV researchers can proceed to test the feasibility and efficacy of MPS- based HIV interventions that utilize MPS to self-monitor. The goal of this project is to develop statistical methods that integrate MPS assessments of social network, diary, and location data to properly assess, model, and predict behavior patterns over time. Such statistical methods will have significant impact on the implementation and evaluation of MPS- based HIV interventions. Prior to modeling social networks in a MPS framework, I need to tackle a methodological social network challenge first. Strategies for measuring and modeling social networks are reasonably well understood in cross-sectional study designs. Methodology to model longitudinal social networks needs to be improved upon to utilize information from social networks in a MPS framework, which results in intense longitudinal data (ILD). Incorrect specification of covariance matrices that do not adequately model time-series patterns can lead to inflated standard errors (Weiss, 2005, Chapter 5), making it harder to detect patterns over time. I will expand on established longitudinal network models by incorporating parameterized covariance matrices, e.g. auto-regressive moving average covariance matrices, to model correlations between repeated assessments over time. Next, I will adapt established Bayesian network models for analyzing MPS-based location traces to the analysis of HIV-related behaviors and activities. I will accomplish this by expanding network models to accommodate the joint analysis of diary and location data. Lastly, I will integrate the analysis of social networks, diary data, and location traces to inform the design of a behavioral self-monitoring mobile phone application. The self-monitoring application will be pilot tested in a sample of HIV-positive adults and inform the design of a MPS-based HIV intervention. The proposed K-award will proceed in three phases, each driven by a specific research aim, as summarized in Table 1. In Phase 1, I will use the expertise I have developed in social network quantitative methods during the training part of the phase to develop statistical methods for analyzing longitudinal social network data in HIV research. Prior to assessing social networks in a MPS framework, there are key social network modeling issues that will only be complicated by a MPS framework and will be more easily addressed outside of a MPS framework first. Modeling longitudinal data in general, calls for appropriate covariance matrices to account for relationships between repeated observations over time. Social network data results in multiple correlated network data at each time point and adds another layer of complexity to the selection of an appropriate covariance matrix. Therefore, my objectives during this phase will be to determine the kinds of covariance matrices that will most likely be present and how to model them. This phase will culminate in a secondary data analysis of longitudinal ego-centric drug-using networks (SHIELD study; Latkin et al., 2003a). The secondary data analysis will test the improved precision I will obtain in modeling drug use by applying covariance matrices my longitudinal social network models will incorporate to a real-world HIV prevention data set. Drs. Bonacich and Latkin will serve as my key mentors during Phase 1 of my proposed study. In Phase 2, training will focus on the assessment and analysis of MPS-based location data. Properly understanding location, travel patterns, and activities, e.g. driving or jogging, through MPS requires modeling the significance of visited places, e.g. grocery stores versus bars, frequency of places visited, and activity sequences, i.e. activities prior and subsequent to a visited place. Bayesian inference provides a natural framework for continuously improving travel pattern predictions because prior data from one model can be incorporated into the next model, and so forth (Gelman et al., 1995). As a result, Bayesian network models have been popular in the analysis of travel patterns between locations (Liao et al., 2004; Patterson et al., 2004). I will build off of my K-award training and prior experience with Bayesian models (Comulada & Weiss, 2007; Comulada et al., 2007) to adapt Bayesian network models to HIV studies. Currently, network models are typically used to predict activity or travel patterns. I will develop network models that incorporate both location traces and self-reported behaviors, e.g. HIV transmission risk behaviors, to predict future behaviors. This phase will culminate in a secondary data analysis of MPS data collected to assess mood, dietary, and physical activity health behaviors. The study, entitled "AndWellness" is currently collecting data under the direction of Dr. Estrin, a co-mentor, through CENS. The secondary data analysis will test the feasibility of using physical activity / location data and self-reported health behaviors to predict future health behaviors through my proposed Bayesian network models. Results will directly inform the modeling of health behaviors in HIV-positive individuals and will be adapted for modeling HIV-related behaviors. Drs. Hansen and Estrin will serve as key mentors during Phase 2 of my proposed study. In Phase 3, I will combine expertise I have developed in social network and MPS data during the first two phases to develop a general framework in which to assess and model longitudinal social network data collected via MPS. Training will focus on research skills I will need to collect MPS data, e.g. training on ethical issues surrounding electronic records. I will expand proposed network models from Phase 2 to incorporate social network data; social network, diary data and location/ activity data will be used to predict future behaviors. I will then formulate statistical modeling strategies for the integrated MPS data as algorithms that can be implemented through a mobile phone application to provide users with a self-monitoring tool. A pilot study will be conducted to test the feasibility of the self-monitoring mobile phone application in a sample of HIV-positive adults and inform the design of a MPS-based HIV intervention. Drs. Hansen and Estrin will guide me in mobile phone implementation of the algorithm. Drs. Bonacich, Latkin, and Li will guide me in collecting appropriate HIV measures and the general study design. Table 1. Training Objectives, Research Phases, Aims and Activities Phase 1 Training Objectives: To gain expertise in social network-related quantitative research methods, especially on longitudinal social network analysis Research Aims: Expand on established longitudinal social network models by incorporating parameterized covariance (PC) matrices and consequently improve the detection of outcome patterns over time Activities : Longitudinal Social Networks. Apply PC longitudinal social network models to understand how social network characteristics influence HIV-transmission behaviors over time in cohort of individuals at risk of acquiring HIV Phase 2 Training Objectives: To gain expertise in quantitative research methods used to analyze mobile personal sensing (MPS) data, especially on the analysis of ILD and GPS location traces Research Aims :Develop model to predict behavioral outcomes using previous measurements of the outcome and previous / concurrently measured diary data and GPS location traces Activities : Diary Data and Location. Apply Bayesian network models to understand how current health behaviors are influenced by previous health behaviors, mood, and background characteristics in volunteers testing health-related mobile phone application Phase 3 Training Objectives: To gain expertise in behavioral study design, with emphasis on qualitative research and electronic data management, and synthesize expertise from Phases 1 and 2 for MPS-based social network data collection and analysis Research Aims: Expand on Phase 2 model by incorporating social network data to predict behavioral outcomes; ultimately, to inform the design of MPS-based HIV interventions Activities : Behavioral Self-monitoring. Pilot test the feasibility of mobile phone application to assist HIV-positive adults in self-monitoring health and HIV-transmission risk behaviors using information reported on themselves and their social network members Each phase of the research is driven by a specific research aim as summarized in Table 1. In the proposed project the aims are: 1. Expand on established longitudinal social network models by incorporating parameterized covariance (PC) matrices and consequently improve the detection of outcome patterns over time 2. Develop model to predict mental health and behavioral outcomes using previous measurements of the outcome and previous / concurrently measured diary data and GPS location traces 3. Expand on Phase 2 model by incorporating social network data to predict mental health and behavioral outcomes; ultimately, to inform the design of MPS-based HIV interventions